Early Academic Achievement and Intervention Response: Role of Executive Function

Recent reports (NAEP, 2022, 2024) reveal that over 60% of 4th graders are performing at or below the basic
level in reading and math; however, successful interventions for struggling upper elementary school learners
thus far have proven elusive. Given the importance of these academic skills, understanding more about the
mechanisms underlying academic success/failure, and how to ameliorate them, is a key public health issue. It is
well established that early reading and math growth are each associated with distinct cognitive skills
(phonological awareness for reading and symbolic magnitude processing for math), but also substantially
overlap, as seen by: (1) the co morbidity between reading and math difficulties; (2) overlap in genetic variance
for reading and math; and (3) the fact that several similar cognitive processes, including executive functions
(EFs), are important cognitive correlates of reading and math. Neurobiological evidence also reveals that while
fMRI tasks elicit skill-specific areas [reading: left occipito-temporal; math: intraparietal sulcus], both reading and
math activate EF regions. Despite these relations, there is little understanding of the neural mechanisms by
which EF-academic linkages develop, and how EF-supported neural networks may relate to intervention
response, especially in upper elementary learners. Current work suggests that while domain general EF
supports initial academic growth, as children develop, domain specific EFs emerge within the context of learning
new skills. The fundamental theoretical premise is that while domain general EF may initially facilitate learning;
to continue to capitalize on EF for positive academic outcomes, EF must become specialized for the task at
hand. As such, we posit that specialization of EF systems (i.e., reading specific EF and math specific EF) must
emerge to support positive academic growth in upper elementary school learners. The overarching goal of this
MERIT Extension is to examine the neurocognitive correlates of the specialization of the EF system and
examine its relationship to academic outcomes in upper elementary school. Aim 1 tests the hypothesis that EF
specialization (i.e., reading specific EF and math specific EF) in 2"d/3'd grades mediates the relationship
between early domain general EF (kindergarten/1 st grade) and later academic outcomes (4th/5th grade). Aim 2
examines how neural systems engage in the context of an intervention, providing a granular probing of neurocognitive
changes as they occur. Aim 2's highly novel approach uses fNIRS (a portable neuroimaging method
that captures brain activity similar to fMRI), which allows for a window into brain changes that are occurring
during instruction. Capturing neural changes during intervention enables more precise tracking of linkages
between EF and reading networks. Overall, understanding domain general EF and domain specific EF across
two timescales - year-by- year, kindergarten through 5th grade, as well as moment-by-moment, during
instruction, will provide key mechanistic insights as to how EF impacts academics. Understanding these
processes may allow for greater specificity of interventional targets to be developed for struggling learners.

Public health relevance
Despite the fact that a substantial number of school age children struggle with both reading and math acquisition, the neural mechanisms of the overlapping aspects of reading and math skills, thought in part to be linked via executive functions (EF), have not been unpacked. To do so, this project follows a longitudinal cohort recruited when the children were in kindergarten through 5th grade, to understand how the neural networks associated with reading, math, and EF interact to predict academic outcomes in upper elementary school and examines how EF-focused interventions bolster academic performance, and the neural networks associated with pre-, post- and during intervention changes. Our ultimate goal is to develop brain-based causal models of academic success/failure so that we can better understand how to effectively individualize instruction in a way that maximizes academic success and prevents academic failure.